Tissue Processing and Histology

ABSTRACT
Tissue Processing and Histology Core
The Tissue Processing and Histology Core will continue to serve the needs of UCSD vision researchers by
providing dedicated tissue processing equipment and a full-time histotechnician experienced in eye
histology and immunohistochemistry. The Tissue Processing and Histology core supports both paraffin and
cryosection processing and various staining strategies. The core also provides vision researchers with 1)
advice for fixation selection depending on study purpose; 2) paraffin and cryo blocking of study samples; 3)
paraffin or cryo histology slide preparation with customized staining, 4) assistance for proper interpretation
and precision microsampling of the region of interest for electron microscopy evaluation and 5) high content
confocal imaging for drug screening and histologic specimen imaging.